HIGH FREQUENCY VENTILATION IN PREMATURE INFANTS

Evaluate whether high frequency ventilation is superior to standard mechanical ventilation in providing ventilatory support for premature infants. As a participating clinical center, Boston Hospital for Women will work with other clinical centers, a coordinating center, and the NIH to develop a protocol and manual of operations for the trial. Boston Hospital for Women will then enroll at least seventy premature infants into the trial, collect the data as specified by the manual of operations, and transmit the data to the coordinating center. Finally, they will work with the other clinical centers and the coordinating center to analyze and interpret the results.